Meaningful Outcome Measures in Adult Hearing Health Care

The current landscape of adult hearing health care lacks standard outcome measures that align with the tools and metrics to assess hearing loss while correlating in meaningful ways with the individual’s perception of their loss and the impact on their quality of life. An ad hoc committee of the National Academies of Sciences, Engineering, and Medicine will examine the state of the science in outcomes research for interventions in adult hearing health care, with an emphasis on measures that are meaningful to the individual and the clinician. The committee will determine a core set of existing standard outcome measures, define the core outcome domains beyond communication that should be measured, and develop a framework and a set of recommendations to guide the development of standardized and meaningful measures that are fit for use in different settings.

Public health relevance
Adult hearing health care lacks standard outcome measures that are related in meaningful ways to the individual’s perception of their functional abilities and the impact their hearing difficulties have on their quality of life. There are many valid ways in which to measure hearing that are an inadequate proxy for self-reported function, and there is limited agreement on which hearing-related endpoints are appropriate to establish therapeutic efficacy or other relevant outcomes. Clinically meaningful, standardized outcome measures in adult hearing health care are needed to rigorously and repeatably establish which interventions improve the lives of people with hearing loss, while determining the quantitative and qualitative aspects of that improvement. This need extends across stakeholders, from individuals with hearing loss to researchers generating the science that drives policy.